Oogenesis and Early Embryogenesis in Drosophila

The goal of this research is to define the cellular and molecular mechanisms responsible for morphological transitions that occur during embryogenesis. Our experiments focus on cycle 14 in Drosophila because the changes that occur at that stage (cellularization and gastrulation) are rapid, simple and reproducible, and can be easily visualized using molecular markers for cytoskeletal and cell adhesion components. Cycle 14 also defines the stage in Drosophila development when the embryo transitions from a complete dependence on maternally supplied gene products to a reliance on zygotic transcription. It thus offers unique genetic advantages for Identifying genes that are relevenat for these processes. Our work is specifically directed at the genes and mechanisms that control cell cycle behavior, global transcription and morphological change. In the next five years, we will continue our analysis of these processes using confocal microscopy of living embryos, classical genetics, molecular biology, quantitative imaging and computer based modeling. Our analysis of cell cycle changes at cycle 14 will focus on String and Twine, two cdc25 homologues that are supplied maternally and whose degradation at cycle 14 appeared to govern the pause in cell cycle that occurs at that time. We will also use chromosomal rearrangements to generate embryos that are missing defined regions of the genome and use the phenotypes observed in those embryos to identify genes that are active at that time. Our initial analysis will focus on the gene or genes located in the centromeric regions of the heterochromatin that are essential for the final fast phase of cellularization. We will investigate the mechanism that control cell shape change in mesodermal cells at the onset of gastrulation, using quantitative imaging and cell reconstructions to analyze the organization of the actin-myosin cytoskeleton and the apical constrictions that occurs in those cells. We will extend this approach to other morphogenetic events of gastrulation.

Public health relevance
RELEVANCE (See Instructions): This is a MERIT Extension application request.